CELLULAR MECHANISMS OF PATHOLOGICAL RETINAL NEOVASCULARIZATION

Retinal neovascularization is an ocular manifestation of diabetes, retinopathy of prematurity and age-related
macular degeneration, which leads to vision loss. Despite the use of anti-VEGF and laser treatments,
progression of retinal neovascularization continues to cause blindness. The development of new therapeutic
approaches against retinal neovascularization is limited, because of lack of knowledge about its
pathophysiology. Retinal neovascularization is characterized by production of several angiogenic factors, with
consequential growth of aberrant new blood vessels on retinal surface that interferes with light transmission
and results in vision loss. An elevated levels of inflammation and inflammatory mediators have been observed in
retinas or vitreous isolated from patients with pathological retinal neovascularization. Therefore, the ability to
modulate inflammation and inflammatory mediators and thereby selectively modulating aberrant retinal
neovascularization, would be a great strategy in the treatment of pathological retinal neovascularization. To
understand the functional significance of inflammation and inflammatory mediators in retinal
neovascularization, we performed preliminary studies using mouse model of oxygen-induced retinopathy. Our
preliminary studies suggest a predominant role caspase-3 and inflammatory caspase (caspase-1) in retinal
neovascularization. Our primary hypothesis to be tested is novel and fills some voids in our understanding
about pathological neoangiogenesis. The specific aims of our proposed studies are to test the hypotheses that
(1) IL-33 and caspases mediates hypoxia-induced pathological retinal neovascularization, (2) IL-33/ST2L
mediated ADAMTS10 or VE-cadherin activation regulates sprouting angiogenesis and vessel branching, and
(3) IL-33/ST2L signaling regulates the functional polarization of inflammatory cells to M2-like macrophages in
hypoxic retina. Achieving these specific aims will elucidate the mechanisms through which various
inflammatory molecules affect retinal neovascularization and open up a new line of understanding about the
pathophysiology of various proliferative retinopathies. In addition, the proposed research will certainly
contribute to the development of new therapeutic strategies against proliferative diabetic retinopathy and
retinopathy of prematurity.

Public health relevance
Pathological retinal neovascularization is the leading cause of vision impairment in US and other developed countries in which neovascularization occurs on the retinal surface that interferes in light transmission and results in vision loss. Current therapies involved in its treatment, either yields modest results or are ineffective in large number of patients. The proposed research on the role of IL-33/ST2L signaling and caspases will help us in understanding the pathophysiology of pathological retinal angiogenesis and may lead to improved therapeutic strategies.